Dissecting the transcription factor networks controlling fetal T-lineage differentiation

Project Summary/Abstract
Multiple sequential waves of T-cell development in the fetal and post-natal thymus give rise to discrete T cell
subsets, each with its own functional properties. Compared with all subsequent waves, the first wave of T-cell
differentiation proceeds very rapidly and gives rise to unique lineages of innate lymphocytes and innate-like
γδT cells. These cell-intrinsic characteristics of first-wave fetal thymocytes suggests that they have their own
separate developmental program. T-cell development is coordinated by a dynamic set of transcription factors
(TFs) with stage-specific activity, through a complex network of regulatory interactions. Significant progress
has been made in recent years in understanding the T-cell differentiation program; however, whether first-wave
fetal thymocytes use the same T-lineage differentiation program is unknown. Through direct comparison of the
transcriptional program of murine adult and first-wave fetal thymocytes by single-cell RNA-seq, as well as
reanalysis of a public scRNA-seq atlas of thymic organogenesis (GSE107910; Kernfeld et al, 2018), I observed
that the first wave of fetal T-cell development occurs simultaneously along two separate trajectories. One
trajectory follows the well-established T-cell development pathway, while the other is used exclusively by first-
wave fetal thymocytes and gives rise to innate lymphocytes and innate-like γδT cells. Cells on this trajectory
appear to use a distinct differentiation program consisting of many TFs typically associated with innate
lymphocyte development—including PLZF and Lmo4—alongside shared T/innate TFs, such as TCF1, GATA3,
and Bcl11b; as well as GATA1 and Meis1, two TFs with no known role in differentiation of either lineage, and
the pan-fetal hematopoiesis regulator Lin28b. I hypothesize that this computationally-inferred population
consists of immediate precursors of innate lymphoid and innate-like γδT-lineage cells, and that their
differentiation is guided by this unique TF network. In Aim 1, I will fate map the progeny of this
hypothesized innate lymphocyte/innate-like γδT cell precursor. Within thymocytes, it is the only population that
expresses Gata1; therefore I will use Gata1CreERT2 x Rosa26lsl-tdT mice to fate map the progeny of Gata1-
expressing cells at embryonic gestational day E13.5. Additionally, I will use clonal barcoding and scRNA-seq at
multiple timepoints to construct a full lineage hierarchy of fetal thymocyte differentiation, and I will perform
scATAC-seq to determine whether lineage priming is occurring in this population or in an upstream precursor at
the level of chromatin accessibility. In Aim 2, I will use CRISPR/Cas9 to delete constituent factors in the innate
lymphocyte/innate-like γδT-lineage program in fetal progenitors and assess the impact of each on
developmental speed and lineage choice. I will also perform scRNA-seq on TF-deleted cells in order to identify
the effect each TF has on the overall program, including how it regulates other members of the program. In this
way, I will use perturbations to construct a network of the regulatory interactions dictating the characteristic
developmental speed and lineage choice of first-wave thymocytes.

Public health relevance
Project Narrative The first wave of thymocyte differentiation in the fetal thymus proceeds rapidly and gives rise to specific lineages of innate lymphocytes and innate-like T cells that are not generated by any subsequent wave of development. Based on my preliminary data, I hypothesize that these populations arise from a dedicated precursor cell in the fetal thymus that is using a unique differentiation program. In this proposal, I aim to test test this hypothesis through fate mapping and perturbation studies to construct a full lineage hierarchy of fetal thymocyte differentiation and the gene regulatory networks that govern it.